Chemokines in healing myocardial infarction

ABSTRACT:
Cell-extracellular matrix (ECM) communication is mediated through the integrins, a family of
heterodimeric cell surface receptors that bind to ECM ligands and modulate a wide range of cellular responses.
Although integrins have been implicated in regulation of inflammation, fibrosis and angiogenesis, their
involvement in post-infarction repair and remodeling remains poorly understood. Our proposal investigates for
the first time the cell-specific roles of integrin signaling in myocardial infarction (MI). Our preliminary data
demonstrate cell-specific roles of 5 integrin (ITGA5) in cardiac repair and post-infarction remodeling:
macrophage ITGA5 protects the infarcted heart stimulating angiogenesis, whereas fibroblast ITGA5 promotes
dysfunction accentuating myofibroblast infiltration in the infarct border zone. Moreover, V integrin (ITGAV)
is markedly upregulated in infarct macrophages and plays a central role in regulation of macrophage phenotype.
Accordingly, we hypothesize that macrophages and fibroblasts sense changes in the ECM composition of
the infarct through integrins, and activate cellular responses critical for repair, remodeling and fibrosis of
the infarcted heart. This hypothesis will be tested in 3 specific aims:
Aim 1: To dissect the mechanisms responsible for the protective effects of macrophage-specific ITGA5
signaling in the infarcted heart. We demonstrated that macrophage ITGA5 protects from adverse post-MI
remodeling through actions that may involve (in part) stimulation of an angiogenic macrophage phenotype.
Accordingly, we will dissect the mechanisms responsible for integrin-mediated activation of macrophages, and
we will examine the relation between integrin expression and macrophage heterogeneity in healing infarcts.
Aim 2: To study the role of fibroblast and myofibroblast ITGA5 in the infarcted and remodeling heart.
Our preliminary data show ITGA5 upregulation in activated fibroblasts and myofibroblasts infiltrating the infarct
and suggest that fibroblast-specific ITGA5 mediates dysfunction and adverse remodeling. Accordingly, we will
use cell-specific integrin KO mice and in vitro assays to explore the role of ITGA5 in regulation of fibroblast
phenotype and we will dissect the molecular cascades mediating ITGA5-stimulated responses.
Aim 3: To investigate the role of macrophage ITGAV in repair and remodeling of the infarcted heart and
to dissect ITGAV-dependent mechanisms of macrophage activation. Our preliminary data show that infarct
macrophages exhibit ITGAV upregulation and that ITGAV blockade modulates the fibrogenic profile of
macrophages. Accordingly, we will use myeloid cell- and inducible macrophage-specific ITGAV KO mice and
in vitro experiments to investigate the role of macrophage ITGAV in repair, remodeling and fibrosis of the
infarcted heart and to dissect the molecular mechanisms responsible for ITGAV actions.
The proposed studies will greatly contribute to our understanding of ECM:cell interactions in the infarcted
heart. Considering the availability of integrin inhibitors, our experiments have important therapeutic implications.

Public health relevance
NARRATIVE: Repair of the infarcted heart requires timely recruitment and activation of immune and reparative cells. The dynamic changes in the extracellular matrix network play a central role in regulating phenotype and function of infarct cells, acting through binding to the integrins, a family of cell surface receptors that transduce signals, regulating cell behavior. Our proposal examines for the first time the role of integrins in macrophages and fibroblastss infiltrating the infarct, investigates central mechanisms involved in repair, angiogenesis and fibrosis, and dissects the molecular cascades modulated by cell-specific integrin activation.